Optimizing Care Delivery to Support Reengagement in PLWH Returning to HIV Care after Treatment Lapses in Zambia

ABSTRACT
Sustained retention in HIV care is critical for viral suppression, but people living with HIV (PLWH) frequently
transition in and out of care over time, putting them at high risk for ongoing viremia and drug resistance. Even
when PLWH return to care after loss to follow-up (LTFU), rates of becoming LTFU again in the future are very
high. Our preliminary data from Zambia suggests that 30% become LTFU again within 6 months, and that 50%
of those who are currently LTFU have previously cycled in and out of care. The time of reengagement in care is
thus a critical period to intervene in this high-risk population, and strategies to improve post-return care delivery
are urgently needed to break ongoing cycles of disengagement. After returning to care, PLWH often report being
scolded, health care workers (HCW) delay ART re-initiation due to adherence concerns and do not consistently
monitor virologic response, and PLWH likely still experience the life situations (e.g., competing obligations, travel
away from home, or psychosocial factors) that led to their initial LTFU. Strategies to 1) target HCW behaviors
(i.e., welcoming returning patients, prompt ART re-initiation) using implementation strategies such as practice
facilitation and audit and feedback and 2) offer PLWH support services tailored to their initial reasons for LTFU
(e.g., extended refills, transfer coordination, peer-navigation) may be promising. To be successful, however, we
need to understand how to effectively implement these approaches into existing care, including 1) how to engage
HCWs in attitude- and behavior-change strategies, 2) what support services to prioritize for different barriers,
and 3) how to integrate activities into existing workflows. This R34 proposal will build the necessary foundation
for implementing a multicomponent reengagement strategy to support sustained reengagement after returning
to HIV care. In Aim 1a, we assess patient and HCW needs and preferences for reengagement strategies with
patient semi-structured interviews (n=20) and focus group discussions with HCWs and clinic leadership (4 FGDs,
n=8-10 each). In Aim 1b, we conduct discrete choice experiments (200 PLWH, 100 HCWs) to quantify relative
preferences for the contents and attributes for our reengagement strategy. In Aim 2, we undertake a human-
centered design process that engages key stakeholders (PLWH, HCWs, clinic leadership, Ministry of Health) in
co-developing the content and features of a multicomponent reengagement strategy focused on 1) improving
the patient reengagement experience, 2) optimizing ART re-initiation and viral load monitoring post-return, and
3) providing tailored services that target individuals’ specific reasons for LTFU. In Aim 3, we will pilot the
developed strategy at one urban and one rural clinic in Lusaka, Zambia. We will use a mixed-methods approach
to assess the implementation (e.g., acceptability, appropriateness), service delivery (e.g., time to ART re-
initiation, viral load monitoring), and clinical outcomes (e.g., retention and viral suppression at 6 months post-
return). Results from this proposal will directly inform a future R01 to formally test this health-system intervention
for patients reengaging in HIV care in a Type II hybrid implementation-effectiveness cluster randomized trial.

Public health relevance
PROJECT NARRATIVE Sustained retention in HIV care is a critical determinant of viral suppression for the 26 million people living with HIV in sub-Saharan Africa, but many frequently transition in and out of care over time, potentially contributing to viremia, drug resistance, transmission, and overall morbidity and mortality. The proposed research seeks to 1) assess patient and healthcare worker needs and preferences for strategies to strengthen reengagement in HIV care and 2) use human centered design to develop and pilot a multicomponent strategy to optimize care delivery and support long-term engagement among patients returning to HIV care after loss to follow-up. This research agenda will lead to a full-scale cluster randomized trial to assess this reengagement strategy to improve long- term patient outcomes and prevent ongoing lost to follow-up in this high-risk patient population, a critical global public health priority.